Core--Histochemistry

The Histochemistry Core provides state-of-the-art technical support, facilities, and collaborative expertise for histochemical and morphological methods needed by the principal investigators of this Program Project. Histochemistry Core services and facilities include tissue fixation and processing (including cryostat sectioning), histological and histochemical staining (e.g., lacZ), immunocytochemistry, fluorescence microscopy, image analysis, and laser capture microdissection. If necessary, the Histochemistry Core can provide in situ hybridization and confocal microscopy. The proposed Director of the Histochemistry Core is Dr. Denis G. Baskin, an established scientist in the fields of histochemistry and diabetes/endocrinology research. He is Research Professor of Medicine at the University of Washington and is also Senior Research Career Scientist in the Seattle VA Medical Center. Dr. Baskin will oversee the administrative and scientific activities of the Histochemistry Core and act as a collaborator on Program Project studies that utilize the core.